Discovery of Potent Selective Inhibitors of the Histone Methyltransferase SUV39H1 for the Treatment of Cancer

PROJECT SUMMARY
Cancer treatment has been transformed by a class of drugs, that includes Keytruda and Opdivo, that enables
the immune system to recognize and selectively kill cancer cells. Unfortunately, many cancers are refractory to
such immuno-oncology (IO) drugs, and so developing novel approaches to augment their efficacy is a high
priority, as these
would undoubtedly lead to a significant reduction in disease mortality. One potentially promising
way to achieve this is to promote the transcriptional reactivation of ancient endogenous retroviruses (ERVs) and
retrotransposons in cancer cells beyond a threshold level of tolerance such that they elicit an immune response,
an approach termed “viral mimicry”. Cancer cells with reactivated ERVs/retrotransposons phenotypically
resemble virus-infected cells and are subsequently recognized and killed by cytotoxic T and natural killer (NK)
cells. We discovered that histone methyltransferase SUV39H1 is a key component of an enzymatic complex that
is essential for the transcriptional silencing of ERVs/retrotransposons in cancer cells. SUV39H1 targeting
reactivated ERVs/retrotransposons in cancer cells, leading to stimulation of intracellular antiviral pathways and
interferon (IFN) signaling. In preclinical studies, SUV39H1 inhibition stimulated the intra-tumoral infiltration of
cytotoxic T/NK cells (i.e., converted “cold” tumors to “hot”), and sensitized refractory tumors to immune
checkpoint therapy. SUV39H1 targeting also exhibited stand-alone antitumor activity by inducing replication
stress and double-strand-breaks (DSB) in cancer cells, presumably by promoting transcription-replication fork
conflicts at reactivated ERVs/retrotransposons. Importantly, SUV39H1 inhibition had no effect on
ERV/retrotransposon silencing in normal cells, indicating a therapeutic window for cancer treatment.
The overall objective of this project is to discover potent and selective SUV39H1 inhibitors with properties suitable
to definitively test our hypothesis that such compounds would be powerful stand-alone antitumor drugs and
immunomodulators. In preliminary studies, we profiled the properties of known SUV39H1/H2 inhibitors (chemical
probes) and provide data from a 1536-well TR-FRET assay that demonstrates robustness and readiness for a
high throughput screen (HTS). Our research plan to advance these preliminary studies has four aims: Aim 1 will
identify selective SUV39H1 hit scaffolds from a 320,000 compound HTS campaign. Aim 2 will utilize a structure-
based design approach to convert a clinical grade SUV39H2 inhibitor into potent SUV39H1-selective
compounds. Aim 3 will use biochemical and ADME assays and iterative cycles of medicinal chemistry to identify
lead compounds with potent cellular activity. Aim 4 will further optimize these leads to compounds with drug-like
properties and explore their stand-alone antitumor and immunomodulatory effects using in vivo cancer models.
The resulting drug leads developed from this study are anticipated to have broad utility to test our therapeutic
hypothesis and represent a critical step in our overall objective to develop SUV39H1 inhibitors as therapeutics
for cancer patients, and specifically those with tumors refractory to IO regimes.

Public health relevance
PROJECT NARRATIVE Immunotherapy has revolutionized cancer treatment, though a significant proportion of tumors are refractory to treatment or ultimately acquire resistance. Therefore, there is an unmet clinical need to develop new immunomodulatory drugs that can enhance the efficacy of immunotherapy in cancer treatment. A potent and selective SUV39H1 inhibitor could lead to a safe and effective therapeutic approach to augment immunotherapy responses, as well as promote stand-alone antitumor responses, through the unique mechanism of induced viral mimicry, undoubtedly leading to a significant reduction in disease mortality.